LOOP GAP RESONATOR DEVELOPMENT &CONSTRUCTION

Several X-band loop-gap resonators are in the final stages of construction. Coupling structure was redesigned to help eliminate thread contact problems and give improved tunability. [unreadable]